Long noncoding RNAs interact with miRNAs to regulate inflammatory response

Summary for lncR MEG3-4 Gram-negative bacteria are important human pathogens that cause high morbidity and mortality, and their increasing antibiotic resistance presents daunting challenges to healthcare. Furthermore, aberrant host defense including excessive inflammatory responses causes detrimental effects following infection, resulting in uncontrollable sepsis and severe outcomes. Long noncoding RNAs (lncRNAs) are important regulators of gene expression; however, their functions in inflammatory responses to bacterial infection are poorly understood. We used a screening approach to identify the lncRNA MEG3-4 as a tissue-specific modulator of inflammatory responses during pulmonary bacterial infection. We also discovered a novel role for microRNA-138 in regulating inflammation through a critical interaction with the lncRNA MEG3-4. Importantly, we revealed a novel mechanism by which MEG3-4 functions as a competing endogenous RNA that binds miR-138 and releases the miRNA's target, IL-1β mRNA. This in turn intensified the inflammatory responses in both cells and mice. These exciting findings prompted us to further dissect the decoy modulation mechanism of lncRNAs in anti- bacterial immunity, as well as assess the impact on phenotype and disease progression in a sepsis model following Pseudomonas aeruginosa infection. We hypothesize that downregulation of MEG3-4 will mitigate Pa infection by soothing the inflammatory response. To test this hypothesis, we propose the following three specific aims: 1, To define the role of MEG3- 4 in host defense against bacterial infection in a tissue-specific manner; 2, To study the molecular mechanisms by which MEG3-4 regulates the inflammatory response against infection; and 3, To determine whether repression of MEG3-4 in critical cell populations will soothe inflammation and help control infection. Completion of this research will dramatically expand our knowledge of the role of lncRNAs and the associated regulatory pathways, which will benefit the pharmaceutical community in their desparate search for new bacterial therapeutics against multidrug resistant strains.

Public health relevance
PROJECT NARRATIVE Gram-negative bacteria, such as Pseudomonas aeruginosa (Pa), are important human pathogens that cause high morbidity and mortality, and their increasing antibiotic resistance presents daunting challenges to healthcare. Non-coding RNAs were considered junk in cells. However, these almost “useless” RNAs are now known to have important functions in various cellular processes including organ development, cell growth, and disease progression. How these non-coding RNAs, especially long non-coding RNAs (lncRNAs), are involved in infectious diseases has yet to be determined. Our proposal is aimed to gain a better understanding of the mechanisms for lncRNA MEG3-4 in tissue specifically regulating inflammatory response as we found in preliminary studies. The central concept for regulating inflammation is its therapeutic targetability. However, since lncRNAs are also important for the development of the immune system and for the body's host defense, this therapy may also have detrimental consequences. Our proposed studies may permit lncRNAs' selective targeting in organ specific roles involved in infection-induced inflammation.